Contribution of cutaneous neuro-immune interactions to chemotherapy-induced peripheral neuropathy

Project Summary
While chemotherapy is the standard of care treatment for many cancer patients, a common side effect,
chemotherapy-induced peripheral neuropathy (CIPN), is the leading cause of treatment discontinuation or dose
reduction. This severe adverse event typically presents in the hands and feet as sensations of weakness, pain,
burning, numbness, or tingling. Oxaliplatin is known to induce the highest incidence of neurotoxicity compared
to other chemotherapies. Chronic oxaliplatin-induced peripheral neuropathy (OIPN) affects about 70% of
oxaliplatin-treated patients, and its major symptoms last for months or years after treatment termination. Slow
spontaneous recovery may occur in some patients, but lingering symptoms often result in permanent nerve
damage. Little is known about mechanisms whereby oxaliplatin induces nerve damage, resulting in OIPN.
The dorsal root ganglia (DRG) sensory nerve fibers extend to the periphery of the body and are known to interact
with immune cells. Neuro-immune interactions are increasingly recognized in the pathobiology of CIPN, and
several different types of immune cells have been implicated in the development of CIPN. However, CIPN studies
have predominately investigated neuro-immune interactions at the DRG level; the peripheral neuro-immune
interactions in the skin (specifically surrounding the hands and feet where CIPN most frequently presents) have
been largely overlooked. To date, there is no comprehensive assessment of these skin neuro-immune
interactions in the context of CIPN. Further, most current CIPN animal models test chemotherapeutic agents
alone without cancer inoculation and effects of cancer on CIPN development are also overlooked.
The objective of this proposed study is to bridge this research gap and characterize the neuro-immune
interactions in the skin of tumor-bearing mice that have OIPN. Our specific aims are to (i) define how the
cutaneous immune landscape is activated by tumor and repeated oxaliplatin and (ii) determine the mechanisms
of cutaneous neuro-immune interactions mediated by tumor and repeated oxaliplatin. Using a tumor-bearing
chronic OIPN mouse model, we will (i) define the cutaneous immune landscape using single cell RNA
sequencing; (ii) determine how nerve and immune cells interact with one another in skin using
immunohistochemistry; and (iii) explore the roles of cutaneous inflammation/immune cell component in OIPN
development using proteomic analysis. Using an in vitro DRG culture system, we will address the effects of
cancer-associated immune cells on the susceptibility of DRG neurons to oxaliplatin.
This exploratory R21 proposal will (i) be the first to rigorously characterize cutaneous neuro-immune interactions
in the tumor bearing and the chronic OIPN setting, (ii) provide robust data essential to establish a more specific
hypothesis which lays the foundation for a future large-scale grant, and (iii) ultimately improve oxaliplatin-treated
cancer patients’ quality of life.

Public health relevance
Project Narrative Chemotherapy-induced peripheral neuropathy (CIPN) is a debilitating sequela that affects thousands of cancer patients daily and significantly reduces their quality of life. This proposal will explore interactions among sensory nerves and immune cells in the skin to test how they contribute to CIPN. The findings from the current proposal could enable us to develop effective therapeutic strategies and diagnostic techniques, resulting in significant improvements in the quality of life of cancer patients with CIPN.